Leveraging Medical Records to Understand the Underreporting of Abortion Before and After Dobbs

ABSTRACT
Dobbs v. Jackson’s Women’s Health Organization, the U.S. Supreme Court’s 2022 reversal of Roe v. Wade, is
the most consequential policy change for maternal and child health in a generation. At the time of submitting this
grant, abortion had been banned or severely restricted in sixteen states, and efforts to impose additional bans
and restrictions are in process in other states. Existing data limit more detailed analysis of who has abortions
and the potential consequences of Dobbs for maternal and child health. The overarching goal of this exploratory
proposal is to use a unique and powerful data resource to characterize the underreporting of abortion, develop
new methods to improve estimates of abortion incidence, and facilitate more research on the consequences of
Dobbs in national survey data. Our specific aims are to (1) document the individual-level determinants of abortion
underreporting in surveys by comparing abortions measured in medical records to survey responses for the
same individuals using a unique sample of study participants; (2) examine how abortion reporting in surveys
changed after the Dobbs decision; and (3) explore the potential to improve national and subgroup estimates
regarding the incidence of abortion in national surveys using evidence from aims (1) and (2). Achieving these
aims will allow researchers to refine national survey estimates of abortion and understand the broader context
in which these decisions occur. The proposed research will also inform a broader and deeper understanding of
the disproportionate incidence of abortion bans or restrictions in the aftermath of Dobbs. The data underlying
this proposal have already been collected and cleaned, making the proposed research highly cost effective.

Public health relevance
PROJECT NARRATIVE This project will advance fundamental knowledge about the measurement and determinants of abortion and the possible consequences of Dobbs in the United States. In addition, this research will contribute to a deeper understanding of maternal and reproductive health and advance research on the effects of public policies, social institutions, and environmental conditions in determining maternal and reproductive health.